The IDeA State Consortium for a Clinical Research Resource Center: Increasing Clinical Trials in IDeA States through Communication of Opportunities, Effective Marketing, and WorkforceDevelopment

There are currently nearly 8,000 clinical trials and observational cohort studies funded by the National Institutes
of Health in the United States, yet less than 10% of these studies are conducted in Institutional Development
Award (IDeA) states that serve underrepresented minority and rural populations. Not surprisingly, only
approximately 7% of expenditures for clinical trials and observational studies go to the 23 IDeA states and Puerto
Rico. Barriers that limit expansion of clinical trial and cohort studies in IDeA states include lack of effective
communication to trial sponsors of the expertise and capability that IDeA institutions possess to effectively
conduct clinical studies, effective communication to IDeA investigators regarding clinical trials opportunities, and
lack of clinical trial coordinators. The overall goal of this project is to increase numbers of clinical trials and
observational cohort studies in IDeA states, thereby increasing trial availability and participation of minority and
rural populations historically underrepresented in clinical trials. We will achieve this goal by establishing the IDeA
State Consortium for Clinical Research Resource Center (ISCORE-RC) comprised of the Clinical Trials Service
Center and the Clinical Research Coordinator (CRC) Development Program to address the identified barriers
through accomplishment of the following specific aims. Aim 1 - Effectively communicate and market to
clinical trial sponsors the expertise, quality, and capacity of IDeA state institutions to conduct clinical
trials. We will accomplish this aim through several tactics to include leveraging the TriNetX platform that
connects clinical trial sponsors with institutions serving relevant patient populations to identify sites with
potentially eligible participants for specific clinical trials, creating a repository containing site-specific profiles
showcasing strengths of individual IDeA state trial groups, establishing an ISCORE-RC website that provides a
public resource to demonstrate benefits of partnering with IDeA organizations to increase clinical trial participant
representation from underserved populations, and facilitating networking of sponsors with investigators. Aim 2 -
Communicate to IDeA state investigators clinical trial opportunities. To accomplish this goal, we will
develop site specific search criteria in clinicaltrials.gov that will allow the ISCORE-RC Clinical Trials Service Core
to monitor relevant clinical trials of interest currently in the participant recruitment phase. Aim 3 - Train a cadre
of skilled clinical research coordinators. Entry into this program will be open to experienced clinical personnel
as well as to non-clinical individuals. Both part-time and full-time effort of trainees will be accommodated. The
program will include an online didactic portion, journal club, and seminar series as well as a prominent
experiential component to be conducted at participating sites. Upon completion of the core content, participants
will receive a CRC basic training certificate and will be eligible for further training towards an advanced training
certificate and membership in the ISCORE-RC CRC Academy, a networking and professional development
platform that includes current research coordinators at participating sites as well as trainees.

Public health relevance
The overall goal of this project is to increase numbers of clinical trials and observational cohort studies in Institutional Development Award (IDeA) states that currently have less than 10% of active NIH supported trials. Strategies to accomplish this goal include communicating to trial sponsors the expertise, quality, and capacity of IDeA state institutions to conduct clinical trials and to IDeA investigators available clinical trial opportunities. We will also train a cadre of skilled research coordinators across IDeA states to provide the necessary workforce capacity to conduct increased numbers of trials.